PERIPHERAL BLOOD LEUKAPHERESIS FOR USE DURING INTENSIVE THERAPY FOR MALIGNANCY

the objective is to demonstrate that peripheral blood hematopoietic stem cells can restore hematopoiesis in patients undergoing intensive chemoradiation therapy.